MANNOSE IN MAMMALIAN GLYCOPROTEIN SYNTHESIS

DESCRIPTION: (from the applicant's abstract) Mannose for N-linked oligosaccharide synthesis is assumed to come from glucose via phosphomannose isomerase (PMI). Dr. Freeze's results challenge this key assumption by showing that mammalian cells have mannose-specific, glucose-tolerant transporters with a K uptake of ~60FM, similar to serum mannose concentrations. Fibroblasts presented with physiological concentrations of glucose (5.5mM) and mannose (50FM), use transported mannose for >70% of glycoprotein biosynthesis, showing that most mannose does not come from glucose in these cells. The principal investigator and his colleagues hypothesize that mannose, and not glucose, is the major source of mannose for glycosylation. Cells briefly deprived of glucose, actively abusing alcoholics, and patients with inherited Carbohydrate Deficient Glycoprotein Syndrome (CDGS) all underglycosylate a specific set of serum glycoproteins because they fail to add entire sugar chains. Adding mannose but not glucose to the culture medium of CDGS fibroblasts corrects underglycosylation and also prevents glucose depletion-induced underglycosylation. The mechanisms are unknown, but they probably result from deficiencies in mannose mobilization. To understand how underglycosylation occurs requires a better understanding of the role of mannose in glycoprotein biosynthesis. The investigators will study the mannose transporter and mannose mobilization in mouse cells and in the organism. Specifically they propose to: 1. Identify the mannose transporter(s) and develop transport assays and antibodies to study its biosynthesis and distribution. 2. Determine if mannose salvaged from normal oligosaccharide processing and exogenous glycoprotein catabolism is used for oligosaccharide biosynthesis. 3. Determine the preferred source of mannose in hepatoma cells under physiological conditions and how other sources compensate when cells are metabolically stressed. 4. Demonstrate glycoprotein digestion and alpha-mannosidases responsible for it. These studies will show the normal sources of mannose for glycoprotein biosynthesis, and may provide insight for other inherited or physiological defects in glycoprotein biosynthesis. In some cases, mannose may be a therapeutic dietary supplement. A mannose supplementation trial for CDGS patients is now underway.